Genetic Mechanisms Driving Evolution of Rickettsiaceae

[unreadable] DESCRIPTION (provided by applicant): The overall goal of the proposed research is to significantly enhance our present understanding of the properties of rickettsiae, a group of obligately intracellular, arthropod transmitted, bacteria which cause at least eleven human diseases in different parts of the world. Orientia tsutsugamushi, Rickettsia akari, R. canada, and R. bellii will be studied. The complete genome sequences of these organisms will be determined to 99.99% accuracy and analyzed by computer to identify the putative RNA, protein encoding genes, pseudogenes, repeat elements, 'selfish DNA', and regulatory elements present in each organism. This information will be provided in publicly accessible databases. Unique and conserved genetic elements found in each rickettsia will be compared to help understand the mechanisms underlying evolution of their pathogenic adaptations. This initial in silico analysis requires biochemical confirmation as it depends upon the similarity of rickettsial gene sequences to well-characterized genetic elements found in other bacteria. Less than 15 of the 1000-2000 genes expected to be present in each of these species have been studied previously. Because of the intracellular lifestyle of rickettsiae and the lack of genetic systems, conventional approaches to characterization of the functional properties of these genes in rickettsiae are limited. Bacterial artificial chromosome (BAC) libraries and DNA arrays containing each gene will be constructed for each rickettsial genome. The BACs and DNA arrays will be used to characterize the expression and regulation of rickettsial genes. Selected rickettsial proteins that may be useful in vaccine development and as potential therapeutic targets will be cloned and expressed to facilitate their characterization. [unreadable] [unreadable] [unreadable]